The UNC Chapel Hill Superfund Research Program (UNC-SRP)

ABSTRACT: THE UNC-CHAPEL HILL SUPERFUND RESEARCH PROGRAM
The interdisciplinary Superfund Research Program at the University of North Carolina at Chapel Hill (UNC-SRP)
addresses serious public health challenges faced by communities in North Carolina (NC) and across the nation
related to inorganic arsenic (iAs). The UNC-SRP prioritizes iAs as the focus contaminant as it is highly relevant
to NC and the US with millions exposed to unsafe levels. In NC, contamination is derived from both geogenic
sources and industrial activities (e.g. superfund sites and coal ash contamination) polluting thousands of
unregulated private drinking wells. An estimated 2.4 million individuals in NC, representing one third of the state’s
population, drink water from private wells with iAs ranging up to 800 ppb. These NC populations may also
experience exposure to other stressors such as poverty or poor nutrition raising environmental justice concerns.
Moreover, iAs contamination reverberates across the state and is locally and nationally-relevant. Related to
public health risk, exposure to iAs has been established to be associated with metabolic dysfunction/diabetes.
There are still significant gaps in the knowledge of factors that drive iAs-induced diabetes risk and methods for
prevention. The identification of these factors would facilitate development of novel solutions/interventions to
reduce the prevalence of iAs-associated diabetes, as well as other diseases associated with iAs exposure. Our
unique scientific theme is “Protecting vulnerable populations from arsenic-induced metabolic
dysfunction with a vision for exposure reduction and disease prevention.” We address this with three
aims: (1) Identify biological mechanisms and susceptibility factors underlying iAs-associated metabolic
dysfunction/diabetes; (2) Develop novel methods and technologies to predict iAs contamination and reduce iAs
exposure; (3) Translate the science of the UNC-SRP to key partners in NC and the larger SRP program, and
engage vulnerable communities. The UNC-SRP comprises four research projects. Projects 1-2 use humanized
mouse models to characterize key developmental windows of susceptibility to iA
s-induced diabetes.
Projects 3-
4 advance the ability to predict iAs contamination in private wells and develop innovative methods for enhanced
removal. The UNC-SRP addresses all four mandates of the national SRP program. Five Cores include the
Administrative Core, Community Engagement Core, Data Management and Analysis Core, Research
Experience and Training Coordination Core, and Chemistry and Analysis Core. These Cores facilitate
administration, chemical analyses, data management/analysis, training, and community engagement with our
partners the Blue Ridge Environmental Defense Fund, Union County Health Department, and Winyah River
Alliance. In sum, the UNC-SRP mission is to protect vulnerable populations from arsenic-induced
disease using mechanistic and translational solution-oriented research to ultimately inform regulation and
Superfund site cleanup efforts.

Public health relevance
NARRATIVE: THE UNC-CHAPEL HILL SUPERFUND RESEARCH PROGRAM North Carolina (NC) communities are impacted by inorganic arsenic (iAs) contamination of soil and water resulting from naturally occurring and industry-derived sources. With relevance to the SRP, ATSDR and US- EPA, the theme of the UNC-SRP is Protecting vulnerable populations from arsenic-induced metabolic dysfunction with a vision for exposure reduction and disease prevention. With relevance to the communities in NC and the US, the UNC-SRP aims to identify biological mechanisms and susceptibility factors underlying iAs-associated metabolic dysfunction/diabetes, develop novel methods and technologies to predict iAs contamination and reduce iAs exposure, and translate and the larger SRP program. the science of the UNC-SRP to key partners in NC